DAMP-RAGE Signaling and Fetal Injury in Inflammation-Induced Preterm Birth

PROJECT SUMMARY /ABSTRACT Strong correlations exist between intra-uterine and/or fetal inflammation, prematurity and incidence of adverse neonatal outcomes, including cerebral palsy. If targeted interventions to improve outcome are to be developed we need to fully understand the molecular mechanisms which inadvertently cause fetal cell damage and tissue injury. Damage-associated molecular pattern molecules (DAMPs) are a pleiotropic group of intra-cellular proteins including high-mobility group box 1 protein (HMGB1) and members of the S100 calcium binding protein family (i.e., S100 A12, S100A8, S100B). When released into the extra-cellular compartment as a result of inflammation or oxidative stress, DAMPs become danger signals by activating endogenous receptors such as the receptor of advanced glycation end-products (RAGE). Engagement of RAGE leads to cellular dysfunction and injury driven by oxidative stress and sustained activity of nuclear factor-kappa B (NFκB). Using proteomics we discovered that S100A12 plays a key role in orchestrating the intra-amniotic inflammatory response to infection via RAGE activation. We have also shown that human fetuses with heightened inflammatory statuses have increased systemic levels of prototype DAMPs such as HMGB1 and S100B. In addition, in a mouse model of endotoxin induced fetal damage we demonstrated that maternal inflammation is associated with fetal oxidative stress and depletion of the intracellular antioxidant glutathione. In the same experimental model we further provided evidence that HMGB1 and RAGE and over-expressed in the liver and brain of the fetuses exposed to inflammation in utero. This body of knowledge, corroborated with the evidence that HMGB1 and S100 proteins are putative RAGE ligands, has led us to propose an active role for the DAMP- RAGE axis in inducing antenatal end-organ damage in the setting of intra-amniotic infection and prematurity. To test this hypothesis, three aims will be pursued: 1) Specific Aim 1 is geared to provide in vivo observational evidence that intra-uterine inflammation induces an imbalance in the redox homeostasis of the human fetus, causing release of DAMP proteins and antenatal fetal cellular damage via RAGE activation; 2) In Specific Aim 2 we will explore, in vitro, the mechanism and functional role of prototypical DAMPs and RAGE signaling in inducing cellular injury in a relevant bioassay. We will test the efficacy of anti-HMGB1 and anti-RAGE blocking antibodies or potential therapeutic agents such as N-acetylcysteine and ethyl pyruvate to reverse the damaging effects of the DAMP-RAGE axis activation; 3) In Specific Aim 3, by using unique genetically engineered RAGE deficient (RAGE-/-) and RAGE transgenic (RAGETg+) animals, we plan to provide insight into RAGE signaling as the common and obligatory pathway leading to fetal damage and explore the value of DAMP and RAGE antagonism as treatment strategies in vivo. By completing these aims we hope to provide novel insight into the processes leading to end-organ damage in premature infants and identify new classes of molecular targets that can modulate the inflammatory response of the fetus and improve outcomes.

Public health relevance
PROJECT NARRATIVE / RELEVANCE FOR PUBLIC HEALTH Damage-associated molecular pattern molecules (DAMPs) and the receptor of advanced glycation end- products (RAGE) are endogenous mediators of cellular injury leading to irreversible tissue damage. We discovered that in pregnancies complicated by intra-amniotic infection, the heightened states of inflammation and oxidative stress have all the requisite attributes to trigger RAGE engagement in vital fetal organs that may explain the increased incidence of poor outcomes associated with prematurity. By using genetically engineered animal models, we aim to provide insight into the pathological consequences of fetal RAGE activation and the potential of RAGE targeted therapeutic interventions to lower the neonatal morbidity and mortality of premature infants. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In mammals, inflammation is a highly orchestrated process developed to fight infection and prevent tissue injury. When successful, inflammation assures restoration of the normal tissue architecture and intact survival of the host. Conversely, the inappropriate control of an inflammatory response may lead to tissue damage and death. Both intra-uterine and maternal systemic infections are important causes of preterm birth (PTB) that likely result from a usually protective inflammatory response that becomes maladaptive during pregnancy. Considerable progress has been made in understanding that the poor outcome of many premature infants in the context of infection is not entirely dependent on the gestational age (GA) at birth, but rather on the consequence of adverse processes that damage the fetus while in utero. Particularities of the fetal response to infection cause pathology unique to the premature fetus including heightened oxidative and inflammatory states that act synergistically with microbial insult to induce damage. The implication of this possibility is startling. If the intra-uterine milieu is harmful to the fetus, any intervention that prevents parturition (i.e. tocolysis) would potentially augment injury unless the damaging processes are also inhibited. To make a difference, it is critical to first understand the molecular mechanisms fueling intra-uterine infection and inflammation into fetal damage and second to develop therapies that will eliminate or limit fetal injury in a targeted fashion. Damage-associated molecular pattern molecules (DAMPs) have been implicated as key mediators of the host's immune response. DAMPs are a pleiotropic group of intra-cellular proteins which when released in the extra-cellular compartment become endogenous "danger signals" by activating membrane receptors leading to further damage. The receptor of advanced glycation end-products (RAGE), a redox-sensitive receptor of immunoglobulin family, acts as a receptor for DAMPs. Engagement of RAGE converts transient stimulation into sustained cellular dysfunction driven by activation of nuclear factor-kappa B (NFκB). In genetic animal models, deletion of RAGE and pharmacological interventions that reduce DAMP levels or block RAGE-DAMP interactions suppress inflammation and dampen tissue damage. The potential to refine therapeutic compounds to target DAMPs and RAGE to prevent fetal damage is exciting. Our laboratory was the first to provide evidence that activation of the RAGE system occurs in pregnancies complicated by intra-amniotic inflammation (IAI) induced by infection. This finding was advanced through the discovery of proteomic biomarkers which allow identification of heightened states of intra-amniotic inflammation and oxidation. The identities of two proteomic biomarkers (S100A12 and S100A8) as RAGE ligands led us to formulate a novel enticing hypothesis: Intra-uterine infection and/or inflammation induces an imbalance in the redox homeostasis of the fetus, causing release of DAMPs and antenatal fetal cellular damage via RAGE activation. We are also driven by the premise that a therapeutical strategy consistent with administration of antioxidants and DAMP inhibitors such as N-acetylcysteine (NAC), ethyl pyruvate (EP), soluble RAGE (sRAGE) or antibodies raised against RAGE or high-mobility group box 1 protein (HMGB1: a prototype DAMP) are beneficial to the fetus by preventing the spiraling of an initial acute inflammatory insult into a self-perpetuated chronic inflammatory state. In a combined human and animal experimental model design, 3 Specific Aims will be pursued: u SPECIFIC AIM 1: To elucidate the "rules of RAGE engagement" in human fetuses by analyzing the concurrent relationships among fetal redox status, release of prototype DAMPs (i.e. HMGB1, S100A12, S100A8 and S100B proteins) and RAGE activation in pregnancies with increasing levels of IAI severity. The results of this aim will provide an observational framework in support of our hypothesis in human pregnancy. u SPECIFIC AIM 2: To determine the net potential of human cord blood derived from fetuses exposed to IAI to induce redox imbalance, DAMP release and RAGE activation in a naïve human endothelial cell (HUVECs) system. We will also determine the ability of blocking antibodies (anti-HMGB1 and anti-RAGE) or select therapeutic agents such as NAC and EP to limit this response. Results from this aim will examine in vitro the mechanism and functional role of HMGB1 and RAGE signaling as effectors of fetal cellular damage. u SPECIFIC AIM 3: To test the hypothesis that DAMPs via RAGE signaling lead to fetal compromise in vivo and that their antagonism with NAC or EP is beneficial to the fetus. This aim will make use of mouse models of PTB induced by systemic inflammation and intra-uterine infection in wild-type and genetically engineered RAGE deficient (RAGE-/-) and RAGE over-expressing (RAGETg+) mice. These results will determine the value of DAMP and RAGE antagonism as treatment strategies in vivo. By completing these aims we hope to provide novel insight into the processes leading to end-organ damage in premature infants and identify new classes of molecular targets which may modulate the inflammatory response of the fetus to improve outcome.